The development and validation of a scale to measure Treatment Regimen Fatigue among older adults living with HIV

ABSTRACT
This application is in response to PAR-21-068 Multidisciplinary Studies of HIV/AIDS and Aging, as well as NOSI
(NOT-OD-21-100) Improving Patient Adherence to Treatment and Prevention Regimens. By 2030, older (aged
50+ years) people living with HIV (PLWH) will comprise 73% of all PLWH. Despite advances in HIV treatment,
older PLWH remain at elevated risk for early morbidity and mortality compared to their peers without HIV due to
the cumulative impact of HIV disease, multimorbidity, and biopsychosocial challenges on disease management.
Treatment regimen/disease-specific fatigue (TRDF)—distress associated with living with, managing, or coping
with a chronic condition, its symptoms and/or treatments—is a key barrier to disease management among people
with chronic conditions. Previous studies estimate that TRDF impacts 33-65% of all PLWH. True values,
however, are unknown, as there is no comprehensive, reliable, and valid tool to assess it. Much of our TRDF
knowledge is derived from 1) studies assessing TRDF with single items; 2) qualitative data from younger,
healthier
PLWH;
3) tools that do not fully capture TDRF and its defining characteristics, such as imbalance
between patient workload and patient capacity; and 4)
data from studies conducted prior to the advent of single-
tablet regimens.
A comprehensive TRDF tool would enable us to identify modifiable drivers of TDRF that could
enable epidemiologic surveillance, inform geriatric assessments, and guide intervention development. Guided
by our novel conceptual model integrating the Workload Capacity Model and Cumulative Complexity Theory and
building on our preliminary work,
the goal of this study is to design and validate a
comprehensive tool to assess
TRDF and identify modifiable factors to facilitate its treatment among older English- and Spanish-speaking
TRDF
among older PLWH with multimorbidity and to refine our novel conceptual model suggest links between TRDF
and poor clinical outcomes, including HIV treatment interruption and unsuppressed viremia. Among those with
multimorbidity, evidence of poor self-management of the co-occurring condition(s) was observed (e.g., high A1C
and/or elevated blood pressure at most recent visit) among those reporting greater disease workload and lower
capacity. Interviews with HIV clinicians suggested that older PLWH may be more susceptible to TRDF than
younger PLWH, and clinicians reported a lack of knowledge and resources regarding TRDF. Our findings
highlight
PLWH with multimorbidity. Preliminary data from our mixed methods study to elicit information about
an urgent need to develop a tool to assess TRDF among older PLWH and assist clinicians with
identifying person-centered interventions to mitigate its effects on disease management. To do this, we will
leverage secondary data from previous work to inform the design of English and Spanish versions of our TRDF
instruments (Aim 1A), which we will then pre-test (Aim 1B. We will then conduct a psychometric study to validate
both versions using rigorous survey development methods, and test our novel conceptual model (Aim 2).

Public health relevance
PROJECT NARRATIVE Treatment Regimen/Disease-Specific Fatigue (TRDF)—distress associated with living with, managing, or coping with a chronic condition, its symptoms and/or treatments—is common in people living with HIV/AIDS, but tools to measure it and approaches to intervene are lacking. The proposed research seeks to finalize and validate a new measure of TRDF among older English-speaking and Spanish-speaking adults living with HIV, including those with additional health issues. This work successfully completed would advance research on HIV and aging by improving the ability to study the impact of TRDF on long-term management of multimorbidity among older PLWH; enabling estimation of the national prevalence and incidence of TRDF in older PLWH; and enabling improved clinical assessment of TRDF and development of person-centered interventions to mitigate its negative effects on HIV-related outcomes.